R,,DB,PC PROSP TRIAL OF EFFICACY &SAFETY OF OXANDRIN IN TX OF DUCHEN

The objectives of this study are to evaluate the effect of Oxandrin on muscle strength and the progression of weakness in boys with Duchenne's MD during a six month treatment period, and to evaluate the safety and tolerability of the drug in this population.